Center for Harmonizing and Improving Interventions to Prevent Suicide (CHIIPS)

Background: The rate of death by suicide has risen by more than 30% in the past 20 years in the U.S. The
rate of death by suicide among U.S. Veterans has risen even faster. Whereas Veterans only constitute 8.5% of
the population, they account for 18% of all suicide deaths among U.S. adults. Although recent declines in
suicide mortality among Veterans may be cause for some hopefulness, they also obscure the dynamics of
suicide mortality and effectiveness of preventive interventions across vulnerable groups. Further, although we
do have methods available to stratify individuals by risk level and interventions that can have positive effects in
terms of reducing suicide attempts, these tools are far from perfect. There is still an urgent need to determine
which available suicide prevention interventions might be the most effective for a given individual at a given
time. Significance: The proposed suicide prevention clinical resource center (SP-CRC) is responsive to
CSRD’s solicitation of applications from VA research facilities to establish an SP-CRC that will serve suicide
prevention investigators by providing highly critical research resources to facilitate programmatic and scientific
needs. The mission of our SP-CRC, the Center for Harmonizing and Improving Interventions to Prevent
Suicide (CHIIPS), will be to advance a precision medicine approach to suicide prevention research. CHIIPS
content area hubs will include Predictive Analytics, Biomarkers, Identification, Screening, Assessment, Social
Determinants/Disparities, Interventions, and (v) Training and Education Innovation and Impact: By
establishing a VA SP-CRC with an explicit focus on promoting precision medicine for suicide prevention, we
will improve individual suicide prevention outcomes, address unsatisfactory response rates for standardized
treatments, promote the incorporation of diverse patient presentations, characteristics, and needs into
treatment plans and suicide prevention research, improve system and population-level outcomes, and increase
efficient use of finite resources (staff, funds, infrastructure). Resources Delivered: At the completion of this
project, we will have provided several resources to the VA suicide prevention research community including: 1)
a portfolio review of VA suicide prevention research portfolio projects on precision medicine, 2) a dataset
repository for use by VA suicide prevention researchers to conduct secondary analyses, 3) the establishment
of precision medicine suicide prevention research postdoctoral fellowships, 4) creation and dissemination of
several recommendations for clinical trials methodology and safety protocols for suicide prevention research,
5) various precision medicine related educational resources for suicide prevention researchers to promote
competent precision medicine suicide prevention research, 6) a statistical and research design consultation
service, 7) funding for precision medicine suicide prevention pilot studies or supplemental funding for ongoing
studies, 8) a literature review of all precision medicine suicide prevention research to date. Coordination with
SPRINT: CHIIPS will work closely with the Suicide Prevention Research Impact Network (SPRINT) PIs and
hubs to optimize synergies and avoid duplication of effort between the two centers. Our goal is to enhance
current SPRINT activities, by leveraging their network and infrastructure to focus on precision medicine
approaches. Together, SPRINT and CHIIPS will help VA Office of Research and Development create a vision
and set priorities for as well as build a precision medicine suicide prevention research portfolio that will
advance the state of the science and help VA achieve its mission of significantly reducing the number of
Veteran suicides.

Public health relevance
The continued high rate of suicide among Veterans, variable successes with currently available suicide prevention screening methods and interventions, and limited use of precision medicine methods in prior suicide prevention research suggests that the field is overdue for a precision medicine approach to suicide prevention. This agenda will require suicide prevention researchers to be trained in precision medicine methods and have the resources needed to conduct much more sophisticated studies than in the past. The immediate goal of this proposal is to advance this agenda by establishing a VA Suicide Prevention Clinical Resource Center with an explicit focus on promoting precision medicine for suicide prevention. In so doing, we seek to improve individual suicide prevention outcomes, address unsatisfactory response rates for standardized treatments, promote the incorporation of diverse patient presentations, characteristics, and needs into treatment plans, improve system and population-level outcomes, and increase efficient use of finite resources.